Cathelicidin in Skin Immunity

RELEVANCE (See instructions):

Public health relevance
RELEVANCE (See instructions): Cathelicidin is a type of antimicrobial peptide known to be important to human disease since infection occurs when expression of this peptide is insufficient, and inflammation occurs when cathelicidin is too abundant. This project builds on a breakthrough discovery into the mechanism of action of cathelicidin to promote inflammation. Our approach seeks to better understand this process and explore potential strategies that can be exploited to treat disease.